REAGENTLESS, BEAD BASED BIOSENSORS

Biotinylated fluorescent ligands are being attached to beads, and studied for cytometry, for the purposed of developing biosensors. This project is described in detail in the year 16-20 NFCR renewal proposal. In brief, the project has three elements: 1) to characterize the interaction of biotiylated ligand with strepavidin beads; 2) to detect energy transfer on the bead surface between ligands and receptors; 3) to use the energy transfer between tethered fluorescent ligands and receptors to monitor the presence of soluble ligands. 1) and 2) have been accomplished. A manuscript for 1) is in preparation; a manuscript for 2) is planned. Novel results include the detection of site-site interactions between ligands on the bead surface using phase sensitive flow cytometry.